The dynamic role of the alveolar macrophage during pulmonary bacterial infection

PROJECT SUMMARY
Gram-negative bacterial pulmonary infections are responsible for significant morbidity and mortality worldwide.
Burkholderia pseudomallei (Bps), a Gram-negative, facultatively intracellular bacterium and Tier 1 Select Agent,
causes melioidosis, a leading etiology of pulmonary infections globally. Pulmonary infection with Bps causes
severe and lethal pneumonia in mice, making aerosolized infection with Burkholderia spp. ideal models for
studying the host response to Gram-negative bacterial pulmonary infections. Alveolar macrophages (AMs) are
a distinct and critical component the initial host immune response to bacterial pathogens, yet little data exist on
the role of AM in Gram-negative bacterial infection. Dr. Sarah Baker developed a research program to define the
role of the AM in host response during Gram-negative bacterial pneumonia using a murine model of pulmonary
melioidosis. She aims to determine the innate immune function of the AM during early pulmonary Gram-negative
bacterial infection and define the role of the AM as a coordinator of the inflammatory response to Gram-negative
bacterial infection during recovery from pneumonia. With the completion of these Aims, Dr. Baker will elucidate
the significance of the AM as an intracellular replication niche for Burkholderia spp. during pulmonary infection
and the mechanisms by which the AM orchestrates the pulmonary inflammatory milieu during recovery from
bacteria-induced pulmonary injury. This improved understanding of host-pathogen interactions in the lung is
crucial to define, and eventually augment, pulmonary host defense in severe bacterial infections. Dr. Baker’s
work is innovative in that she blends in vitro and in vivo studies with immunomodulatory polymers and chimeric
mouse models to rigorously study a pathogen (Bps) that poses a severe emerging infectious risk given its
potential as a bioweapon and newly confirmed environmental presence in the United States.
Dr. Baker is a Senior Fellow in the Division of Allergy and Infectious Diseases at the University of Washington
and a physician-scientist with an interest in pulmonary immunology and emerging infectious diseases research.
To complement her proposed research goals, Dr. Baker also devised an accompanying Career Development
Plan to provide her with advanced research training in microscopy and imaging, innate immunology,
immunoengineering, and lung injury. She will collaborate with a multidisciplinary team at the University of
Washington that includes experts in pulmonary host defense and bioengineering to provide targeted mentorship
for this proposal. By the conclusion of this Award, Dr. Baker will transition to a role as an independent physician-
scientist. She will contribute to the scientific community by providing mechanistic insight into the innate immune
function of the AM during Gram-negative pulmonary infection and effectively probing these pathways using
immunomodulatory polymers.

Public health relevance
PROJECT NARRATIVE Bacterial pulmonary infections cause significant morbidity and mortality worldwide. This project seeks to delineate the role of alveolar macrophages, an innate immune cell in the lung implicated in multiple components of the host response to pathogens. The results of this proposal will provide an improved understanding of the innate immune response to bacterial infection in the lung and augment the potential for the development of host directed therapeutics.